Precision pharmacology by local control of opioid receptors in neural circuits

PROJECT SUMMARY
This proposal seeks to leverage the emerging understanding of cellular and subcellular heterogeneity in opioid
signaling for therapeutic discovery. The project develops new optogenetic and chemogenetic tools to achieve
local control of opioid receptor activity and signaling in neural circuits and at a subcellular level of resolution. The
proposal seeks to develop a versatile toolbox and provide proof-of-concept for "in vivo precision pharmacology"
that have not yet been applied to the opioid system. The first phase (R61) is a "high-risk" technology enabling
phase, based on combining our collaborative team's expertise in developing receptor-blocking intracellular
nanobodies with established methods for conferring local control of nanobody concentration in the cytoplasm
and specific membrane domains, using optogenetic and chemogenetic strategies that have already been
validated but never before applied to opioid receptors. The R61 phase will develop these tools (Specific Aim 1)
and validate them in neuronal culture and acute slice preparations (Specific Aim 2). These studies will provide
not only proof-of-concept for in vivo precision pharmacology of opioid receptors, but also for G protein-coupled
receptors as a class. We have set a specific series of milestones to evaluate progress, and to assess feasibility
for advance to in vivo studies. If the milestones are successfully met, the second phase (R33) will apply the new
tools to selectively target opioid signaling in neural circuits in vivo, focusing on analgesia, behavioral
reinforcement and respiratory depression by clinically relevant opioid drugs. Mice are used as a well-established
and relevant model (Specific Aim 3). These studies leverage the combined expertise of our collaborative team,
and will establish powerful optogenetic and chemogenetic manipulations for the study of in vivo opioid function
for the first time. Accordingly, the proposed studies to provide the first-in-class application of optogenetic and
chemogenetic control to the opioid system in vivo, and they will explore a precision pharmacology of opioids
based on location in neural circuits.

Public health relevance
PROJECT NARRATIVE Addictive opiate drugs such as morphine and heroin activate the same cellular receptors as endogenous opioid neuropeptides, yet produce pathological effects after prolonged or repeated administration. The proposed studies develop first-in-class optogenetic and chemogenetic tools to locally block opioid receptor function according to cellular and subcellular location in neural circuits. The goal of the studies is to provide a proof-of- principle for development of location-based precision pharmacology to increase the therapeutic index of opioid drug action.